The IGNITE II CC: Engagement, Coordination, Demonstration, and Dissemination

Project Summary This administrative supplement is requested to support the needs for the IGNITE Pragmatic Trial Network Coordinating Center (IGNITE PTN CC, U01 HG010225) to assist the International HundredK+ Cohorts Consortium (IHCC), administratively supported by the Global Genomic Medicine Collaborative (G2MC), to focus on NHGRI’s interest in research on pressing public health questions that can uniquely be addressed by collaborative efforts of large international cohort studies. The IGNITE PTN CC will enable advancement of the IHCC through the following aims: Aim 1: To provide coordination, logistical, and process resources for the G2MC secretariat to a) support the successful completion of cross-cohort global scientific projects initiated in 2019-2021, b) provide ongoing operational support for the IHCC leadership teams, c) prepare and support global virtual and face to face meeting agendas and their logistics, d) continue to build a robust and interactive cohorts’ community, and e) complete and launch its 5-year strategic plan. Aim 2: To develop and implement information technology strategies for the IHCC to enable identification of cohorts for participation in cross- cohort scientific projects (i.e., cohort “discovery”), the sharing of expertise and scientific findings, and to grow the IHCC community. This aim will be accomplished through a) support of the IHCC Global Cohorts Data Atlas development, b) development of IHCC workshops and regular seminars, and c) web presence and outreach to the Duke University and broader scientific community. By accomplishing these aims, the G2MC secretariat will increase representation of ancestrally and geographically diverse cohorts in recently awarded projects and IHCC leadership teams by enriching involvement with cohorts in low resource settings (LRS) and low- and middle- income countries (LMICs) and building a cohesive and interactive cohorts community. This supplement will also identify cohorts for participation in cross-cohort projects through expansion of the IHCC Global Cohorts Data Atlas. The Atlas utilizes a federated data discovery model and harmonizes cohort level metadata via a portal for search and discovery of relevant human data. Cross-organizational initiatives will develop and disseminate shared standards and best practices with our network of professional organizations with similar missions [e.g., the Global Alliance for Genomics and Health (GA4GH) and the International Common Disease Alliance (ICDA)] thus optimizing our investments. Developing a planned series of educational forums for good scientific exchange of ideas and lessons learned will strengthen knowledge dissemination beyond the IGNITE PTN and IHCC. Dissemination of shared knowledge and communications to the broader scientific community will be accomplished through web-based strategies and social media channels. In summary, we will facilitate interactions between and among cohorts to create a global platform for translational research, informing the social, biological and genetic basis for disease to improve clinical care and population health.

Public health relevance
Project Narrative This project will leverage the expertise of the IGNITE Pragmatic Trials Network to facilitate the coordination of global programs and their dissemination and communication with relevant communities outside the network. Specifically, this administrative supplement will assist in the advancement of the International HundredK+ Cohorts Consortium (IHCC) through the deployment of the robust management structure of the Global Genomic Medicine Collaborative to support the administrative functions of the IHCC and to facilitate cohort discovery and dissemination of knowledge. The overarching goal is to link and facilitate interactions between and among cohorts to create a global platform for translational research, informing the social, biological and genetic basis for disease and improving clinical care and population health.